MEDICAL AND SURGICAL COMPLICATIONS OF PREGNANCY

Over the past 25 years many techniques have been developed and tested in the PCRC. This protocol provides a format and process for admission and management of the PCRC patients. This process of patient admission and study is a central component of Center operations upon which the PCRC's ability to support multiple research studies is based. This protocol includes admissions early in pregnancy for diabetics who participate in research later in gestation.